Administrative Core

ADMINISTRATIVE CORE (AC): ABSTRACT
The Administrative Core (AC) of the Center of Excellence in Environmental Toxicology (CEET) is
under the effective leadership of two seasoned investigators with endowed chairs: Trevor M.
Penning, PhD (The Thelma Brown and Henry Charles Molinoff Professor of Pharmacology) and
Sharon McGrath-Morrow, MBA, MD (The Robert Gerard Morse Endowed Chair in Pediatric
Pulmonary Medicine). These directors enable translational environmental health research in adult
and pediatric populations. Leaders of thematic areas in: Air Pollution & Lung Health,
Environmental Exposures & Cancer, Windows-of-Susceptibility, and Environmental
Neuroscience, join the leadership team and are of international repute, and promote team science
within their areas and in the cross-cutting themes of exposomics and the effects of extreme
weather on health. This leadership team ensures that the goals of the CEET strategic vision to
elevate the environmental health identity of the Center at the institutional, regional, and national
levels is achieved. The AC provides oversight of the Translational Research Support Core
(TRSC), the Biomolecular Mass Spectrometry Core (BMSC), and the Environmental Health
Informatics Core (EHIC) so that they are responsive to investigator needs. The AC coordinates
communication and interaction with the Community Engagement Core (CEC) to bring community
concerns to the attention of thematic area leaders and the TRSC. Evaluation and decision making
are overseen by the Internal Advisory Committee, the Executive Committee, the Directors
Council, and the External Advisory Board, and by a periodic SWOT analysis. Compliance with
the Data Management & Sharing Plan and the preparation of reports and fiscal management are
supported by an experienced Director, Center Administrator, and Grants Manager. The AC
recruits new faculty and brings its members together by organizing working groups, thematic area
talks, research in progress talks for trainees, a seminar series, and annual symposia. The CEET
is the hub for all Environmental Health Science training at Penn and the training mission is
overseen by the AC. In this role, the AC uses a Career Development Program (CDP) to cultivate
the careers of Early-Stage Investigators (ESI). Our CDP believes that environmental health
science is unique since it spans interdisciplinary expertise ranging from exposure science,
mechanistic toxicology, epidemiology, and translation to patients, communities, and policy
makers. Environmental Health (EH) scientists are faced with “Big-Data”, and how to transform
such data into knowledge requires familiarity with informatics tools and advances in machine
learning and AI. Our CDP provides a transformative experience so that our ESI will be equipped
with the tools for success as future EH scientists. The AC builds capacity by bringing senior
investigators into the CEET who are addressing environmental health problems for the first time.
In this manner, the AC is responsive to the current NIEHS strategic plan, which stresses
stewardship of resources and building a pathway for professional development.